Impact of multidisciplinary evaluation of treatment and outcome for hepatocellular carcinoma in Tanzania

PROJECT SUMMARY
This mentored IRSDA-K01 from University of California Davis (UCD) and Muhimbili University of Health and
Allied Health Science (MUHAS) Tanzania will support Dr. Cameron Gaskill, Assistant Professor of Surgery, to
establish an impactful, independent global health research program addressing liver cancer in sub-Saharan
Africa (SSA). Liver cancer, or Hepatocellular Carcinoma (HCC), is the third leading cause of cancer related
mortality worldwide. In SSA, < 5% of patients receive curative treatments. In Tanzania, improving care for HCC
patients has become a top priority for the Ministry of Health. This K01 will establish a knowledge base and
infrastructure that prospectively captures highly annotated treatment information and outcome metrics. The
goal is to evaluate care delivery factors and identify areas to expand curative treatment strategies culminating
in a clinical trial investigating the safety and efficacy of surgical resection for HCC beyond current practices.
The Aims are to 1) Pilot a national liver cancer treatment outcomes registry to assess the impact of location
and resource availability; 2) Utilize multidisciplinary tumor board performance index to assess impacts of the
Multidisciplinary Liver Tumor Board on care delivery and outcomes in Tanzania; and 3) Evaluate the safety and
efficacy of curative surgical resection of HCC extended beyond Barcelona Clinic Liver Cancer Staging
recommendations. Paired with these research aims, the training goals will provide Dr. Gaskill with the skills and
experiences necessary to build an independent global health research program as well as run clinical trials in
SSA. The training goals will develop skills to 1) Implement clinical registries; 2) Assess key performance
indicators of clinical programs; 3) Perform advanced statistical analysis of epidemiologic and clinical data; 4)
Design effective and resource appropriate clinical trials; 5) Become an effective global oncology leader and
mentor; 6) Develop an R- level proposal based on these research findings. Through this process Dr. Gaskill will
cultivate the leadership, professional skills, and research partnerships necessary to become an independent
global health research scientist. Dr. Gaskill will be guided by a team of experienced mentors led by Dr. Elia
Mmbaga (LMIC mentor, MUHAS), a globally recognized leader in cancer epidemiology in Tanzania, and Dr.
Brad Pollock (UCD mentor), national leader with expertise in epidemiology and clinical trial study design. In
addition, an outstanding team of contributors will provide content expertise including Dr. Katherine Van Loon,
global cancer care research, training, and leadership expertise, Dr. Ally Mwanga, hepatobiliary surgery and
global oncology research expertise at MUHAS, and Dr. Edward Kim, clinical trial design and administration
expertise at UCD. The prolonged field experience and collaborative research supported by this IRSDA-K01,
coupled with strong institutional support from UCD will cultivate a sustained international research partnership
with Dr. Gaskill and MUHAS aimed at improving HCC outcomes in SSA.

Public health relevance
PROJECT NARRATIVE Liver cancer is the third leading cause of cancer-related mortality; however, less than 5% of patients in sub- Saharan Africa are provided treatment beyond palliative measures. A knowledge base and infrastructure that prospectively captures highly annotated treatment information and outcome metrics is needed to evaluate care delivery factors and identify areas to expand curative treatment strategies. We propose to examine liver cancer treatment and related outcomes, as well as multidisciplinary tumor board impact, to then evaluate expanding surgical resection as a curative treatment to a larger population of patients in Tanzania.